Mechanisms of epithelial tube development, orientation and integrity

Project Summary
Epithelia are sheets of polarized cells that that transport fluids,
cells, and gasses. These tubes are the building blocks of organs, glands and embryonic endoderm. To
understand the biology of epithelial tubes, we need to define the
often organize into tubes, specialized tissues
mechanisms that control epithelial patterning
and integrity. However, because of the great variety of epithelial tubes across animals, we must expand our
investigation into new model organisms so that we can determine the fundamental and shared mechanisms of
tube development. we have recently established
the larva of the sea star Patiria miniata as an innovative model that leverages
while
To address this challenge and uncover general mechanisms,
the experimental advantages of a
small invertebrate sharing a close phylogenetic position to vertebrates. Taking advantage of the first genetic
tools (CRISPR Cas9) and long-term live imaging methods that we established for sea stars, our proposal will
address three fundamental questions of epithelia biology. First, how is the orientation and shape of epithelial
tubes controlled? Our recent work found that the Wnt pathway regulates tissue orientation through the Frizzled
1/2/7 receptor and uncovered a new role for Dishevelled in controlling lumen shape, but the mechanisms
activated by these effectors remain unknown. Second, what molecular mechanisms keep tube cells in an
epithelial state? In our preliminary data we found that tube cells that are blocked in G1 of the cell cycle undergo
epithelial to mesenchymal transition (EMT) and leave behind a disrupted basal lamina, damaging tissue integrity.
We will leverage these methods that precisely induce EMT to investigate whether there are external cues or cell
intrinsic factors that trigger EMT from a tube, a pathological process that is poorly understood. Third, how does
the gene regulatory network that defines epithelial cell lineages change over time, from the initial tube to a more
complex structure? Our recent work has shown that the FGFR induces expression of the transcriptional factor
Six1/2, that in turn regulates branching points, thus defining a first node in the GRN. But how the GRN integrates
information from all the genes expressed by different cells, and what are the basic cell-types that are conserved
in evolution to build a solid tube has not been defined yet. Major key gaps remain in our understanding of the
integration of signaling pathways, cell cycle and gene networks that guide epithelial tube morphogenesis. The
tools we developed, the advantage of a novel experimental system and the multipronged approach we will
undertake in these projects uniquely position us to address these gaps. Our results will improve our
understanding of the conserved mechanisms of tube morphogenesis and may provide insights on a broad range
of epithelial diseases in
humans
, including congenital disorders, tissue fibrosis, organ malfunctions and cancer.

Public health relevance
PROJECT NARRATIVE Tubular tissues are broadly employed across multicellular organisms to build structures that are vital to support life, such as organs, glands, and the vascular system. By leveraging the novel sea star system, a close relative to vertebrates that offers powerful experimental tools, this proposal will contribute to our understanding of the conserved mechanisms for building biological tubes with a precise orientation and shape, and the genes that govern this process. The results of this proposal will form the foundation to advance our understanding of diseases that affect tubes in our body, with a broad impact on human health.